Structural and functional neural alterations in suicidality among Veterans with PTSD

PROJECT SUMMARY/ABSTRACT
Research: Veterans of the U.S. military die by suicide at a rate of two to six times that of their civilian
counterparts. Suicidal ideation (SI) and suicide attempts (SA), cardinal precursors to death by suicide, occur at
significantly greater frequency than death and cause immense individual and societal burden, yet relatively
little is known about their pathophysiology. This is especially so in posttraumatic stress disorder (PTSD), a
signature injury of the wars in Iraq and Afghanistan. High rates of comorbidity and inflated prevalence of both
suicidality and PTSD in Veterans, highlights the urgency of advancing understanding of the shared and
distinguishing neural mechanisms between these. Evidence of trauma- and stress-related synaptic loss and
large-scale alterations in intrinsic connectivity networks in brain regions implicated in mood, cognition, and
behavior exists in both SI/SA and PTSD literature. However, a major obstacle in field is the scarcity of
neurobiologically-based studies of SI/SA in PTSD cohorts. Preliminary data supports the notion that the
location and pattern of synaptic alterations may interact with individual and environmental characteristics to
affect clinical presentation and symptom severity. Specifically, Veterans with PTSD endorsing SI appear to
have a neural signature of synaptic alterations distinct from PTSD symptom severity, depression, and age.
Extending this work, state-of-the-art multimodal neuroimaging and behavioral assessment sessions will be
conducted in 96 Veterans across 3 study groups (n=32/group): PTSD only; PTSD+SI; PTSD+SA. Robust,
complimentary evidence of a unique pattern and location of synaptic alterations will be demonstrated using (a)
whole-brain vertex-wise structural magnetic resonance imaging (MRI) to measure cortical thickness, (b)
resting-state functional connectivity MRI (rs-fcMRI) to measure global brain connectivity (GBC), and (c)
diffusion MRI to measure diffusion GBC (dGBC), a measure of microstructural architecture and connectivity.
Veterans will be matched on age, sex, PTSD symptom severity, and history of traumatic brain injury. This study
may identify biomarkers of treatment targets in two of the operational priority areas for the VA – suicide and
PTSD, inform novel drug development of efficacious pharmacologic interventions, and ultimately advance the
field making way to alleviate suffering of millions of individuals – Veteran and civilian alike - struggling with
suicidality.
Candidate: Dr. Averill has demonstrated an unwavering commitment to improving Veterans’ mental health
care, with emphasis on PTSD and suicide prevention for well over a decade. Short-term goals include receipt of
the CDA-2 to both advance her expertise through rigorous training objectives (focused on the neurobiology of
SI/SA, multimodal neuroimaging, and statistics) and to provide data for future funding as she establishes a
niche program of research in the National Center for PTSD-Clinical Neurosciences Division (NCPTSD-CND).
Long-term goals include becoming a thought leader in the areas of suicide prevention and PTSD in Veterans
through empirical investigations aimed at informing novel drug development and improved prevention,
diagnostics, identification of biomarkers of risk and resilience in SI/SA, and treatment options.
Environment: The infrastructure, quality of mentors, supplementary funding support, technology, and
Veteran-focused research environment available at the National Center for PTSD-Clinical Neurosciences
Division and Yale are unparalleled. This offers unique opportunity to support Dr. Averill in her transition to
independence though exceptional targeted training/mentorship and to conduct a low cost/high yield study
with great potential to advance the field, lead to improved outcomes for Veterans, and set a foundation for a
successful VA-centric career.

Public health relevance
PROJECT NARRATIVE Suicide prevention and PTSD are operational priorities for the VA due to high rates of comorbidity and inflated prevalence rates in Veterans. The field is currently limited by a paucity of research on neural mechanisms underlying suicidal ideation (SI) and suicide attempts (SA) in PTSD. This proposal aims to fill a major gap in the literature by providing robust evidence of a distinct pattern and location of synaptic loss and dysconnectivity of SI/SA in PTSD using state-of-the-art multimodal neuroimaging. If these aims are accomplished, the identified biomarkers of treatment targets could (1) inform novel drug development of efficacious pharmacologic interventions, (2) improve prevention, diagnostics, and risk identification for SI, SA, and PTSD, and (3) ultimately advance the field making way to alleviate suffering of millions of individuals – Veteran and civilian alike - struggling with suicidality.